In vivo 2-photon imaging of retinal biochemistry before and after retinal organoid transplantation

Project Summary
Candidate and Career Development Plan: Dr. Browne is an assistant professor practicing vitreoretinal surgery
and functioning as an engineer and physician-scientist at the University of California, Irvine. Dr. Browne
established his engineering and basic biological sciences skills as a PhD student. He has balanced clinical duties
with his laboratory research activities and. His long-term career goals are to engineer functional imaging tools
that will advance the understanding of early and advanced eye diseases and facilitate the therapies needed to
treat humans. His training thus far has been using in vitro imaging alone. To achieve his career goals, he is
requesting support for training to develop functional imaging tools in vivo and the molecular tools to correctly
interpret Two-photon imaging (2PI) observations from animal models. This K08 award will enable Dr. Browne to
develop his scientific and professional skills in advanced imaging, fluorescence microscopy, and retinal cellular
biology applied in vivo. Dr. Browne and his co-mentors, Drs. Palczewski, Seiler and Kuppermann, have
developed a hands-on strategy to fulfill the training requirements through relevant course work, didactics,
laboratory techniques, and collaborations at UC Irvine. The training program will prepare Dr. Browne to submit
R01-level proposals to independently investigate and optimize functional retinal imaging as a tool for therapeutic
discovery.
Research Plan: Many blinding retinal conditions, like age-related macular degeneration, are the consequence
of biochemical dysfunction and the secondary effects of inflammation and cell death. Conventional clinical tools
provide valuable structural information about the retina but are unable to visualize retinal function. Non-linear
optical imaging can now reveal subcellular biochemistry in vitro and has emerged as a reliable tool to study
retinal disease. 2PI in mouse models demonstrates subcellular changes in energy and light cycle metabolism.
Cell replacement therapy has emerged as a therapeutic candidate for advanced vision loss, and preclinical trials
in rats have demonstrated visual function restoration. To understand metabolic function in retinal organoids
(RtOg) before and after transplantation into blind rats, we will employ functional 2PI in vitro and in vivo as outlined
in the following specific aims. 1) Investigate RtOg maturation with 2PI and correlate functional imaging data with
cell-specific reporters in vitro and molecular signatures post vivo, 2) Identify functional imaging biomarkers for in
vivo metabolism using 2PI of normal rats and rat with retinal degeneration, 3) Study in vivo functional 2PI of
transplanted RtOgs in rats to identify alterations in functional imaging biomarkers and correlate imaging findings
with visual function testing. Completion of these aims will yield time-resolved metabolic detail for specific cell
populations in developing RtOgs, avail novel in vivo information about retinal biochemistry in healthy retina,
diseased retina, and diseased retinas treated with retinal sheet transplantation. These discoveries will guide
future translation of both functional imaging and tissue replacement therapy in humans.

Public health relevance
No other imaging modality can non-invasively visualize the subcellular biochemistry revealed by 2-photon imaging (2PI). 2PI will be an important clinical assessment tool for genetic, molecular and tissue transplantation therapies that restore cellular function. I want to use 2PI to investigate the biochemistry of live host and transplanted retinal tissues because understanding in vivo changes in the biochemistry is crucial for establishing objective endpoints for novel treatments that target advanced retinal degeneration.